Membrane signaling protein modulation by lipids and drugs

Project Summary/Abstract
The goal of this project is to understand at the atomic level how cholesterol modulates integral membrane protein
signaling. We seek to address this question in two physiologically important biological pathways, cholesterol
homeostasis by the SREBP regulatory machinery and hormone signaling by G protein-coupled receptors
(GPCRs). The SREBP machinery centers on Scap, a membrane protein that resides in the endoplasmic
reticulum. Scap binds to the SREBP transcription factors and controls their maturation in a cholesterol-dependent
manner. There are currently no atomic structures of any vertebrate Scap, and little is known at a detailed
biophysical level about Scap's cholesterol binding or conformational changes. Like Scap, GPCRs bind ligands
(e.g. hormones, neurotransmitters, and lipids) and undergo conformational changes that trigger intracellular
signaling. Multiple GPCR X-ray structures have revealed cholesterol binding interactions, however the functional
significance of these interactions is largely unknown. We found that the CB1 cannabinoid receptor can bind
allosteric modulators at a membrane-embedded surface that overlaps with its cholesterol binding site. This
finding suggests that cholesterol may be an allosteric modulator of CB1 as well as other GPCRs. We are studying
the interactions of cholesterol with Scap and GPCRs to better understand how this essential lipid can control
diverse functions through these different membrane proteins. We will use cryo-EM to determine the atomic
structure of a full-length vertebrate Scap, either bound to its co-regulatory membrane protein Insig or a soluble
fragment of SREBP2. These structures will elucidate the architecture of this lipid-sensing machine and provide
an atomic basis for cholesterol regulation. In parallel, we will obtain the first NMR spectroscopy data and cryo-
EM structural data for GPCRs embedded in native-like phospholipid nanodiscs, with and without cholesterol.
These data will reveal whether embedded cholesterol can stabilize particular conformations of a GPCR, and
whether cholesterol interactions are maintained in G protein signaling complexes. We propose to use this diverse
array of biophysical techniques to obtain unprecedented atomic data on cholesterol regulation of these systems,
and our findings may be used to help develop drugs that modulate Scap or different GPCRs through the
membrane.

Public health relevance
Project Narrative The goal of this project is to understand how cholesterol interacts with physiologically important membrane proteins to control their signaling functions through modulating conformational changes. We will use a diverse set of biophysical techniques to study cholesterol interactions with Scap, the master regulator of mammalian cholesterol homeostasis, and GPCRs, which transduce signals from hormones and neurotransmitters to intracellular G proteins. Further understanding how cholesterol influences the conformations of these proteins will benefit public health, since Scap is a potential therapeutic target for fatty liver disease, and different GPCRs are important for treating many disorders such as asthma, cardiovascular disease, and Parkinson's disease.